Intestinal Inflammation: Signaling proteins and the rate of PMN transmigration

Abstract
Recent reports by our group and others have highlighted the beneficial and detrimental nature of innate
immune cell interactions with intestinal epithelia. Indeed, as observed in Inflammatory Bowel Disease (IBD), an
excessive inflammatory response not only results in mucosal injury but is also detrimental for wound repair. We
are now beginning to appreciate that intestinal wound repair is regulated, in part, by common receptors
expressed on both leukocytes and intestinal epithelial cells (IECs). We recently determined that the
ubiquitously expressed membrane protein CD47 is necessary for regulating mucosal wound healing in the
intestine and our current data indicates a role for CD47 in both neutrophil (PMN) recruitment and IEC
migration. Our preliminary data suggests that CD47-deficient IECs and PMN express less thrombospondin-1
(TSP1), a soluble ligand for CD47, which promotes PMN recruitment to injured mucosa. PMNs, as the first
responders, also secrete Leukotriene B4 (LTB4) that binds to its high affinity receptor BLT1 expressed on PMN
and amplifies their recruitment. Interestingly, we recently found that IECs also express BLT1 and its ligation by
LTB4 promotes mucosal wound repair. In this project, LTB4 and TSP1 are separately evaluated as ligands for
receptors expressed on PMNs and IECs during inflammation and repair in the gut. We will build on our
preliminary data and previous studies to move toward our goal of understanding mechanisms regulating
mucosal wound repair under inflammatory conditions as seen in IBD. These studies will not only shed new light
on the complex interplay between inflammatory cells and epithelial cells in orchestrating intestinal mucosal
injury/repair in health and disease but may provide new ideas for druggable targets to promote wound repair
during mucosal inflammation.

Public health relevance
Narrative Dysregulated intestinal inflammation results in mucosal injury and impaired healing responses. Efficient repair of intestinal mucosa is dependent on complex events involving crosstalk between receptors on the epithelium as well as immune cells that are recruited to sites of injury. A better understanding of complex interplay between inflammatory cells and epithelial cells in orchestrating mucosal repair may provide ideas for druggable targets to promote healing during mucosal inflammation.